Targeted protein degraders for the treatment of b-hemoglobinopathies

Globally, 300,000 babies are born annually with Sickle Cell Disease (SCD). Current therapies for
SCD revolve around induction of fetal hemoglobin (HbF), as it critically antagonizes red blood cell
sickling. For example, hydroxyurea, a ribonucleotide reductase inhibitor, increases HbF levels.
While hydroxyurea is the standard of care treatment for prevention of sickle cell crises, its effect
on HbF induction can be weak and is variable from patient to patient. Attention has recently shifted
to targeted gene therapy and gene editing efforts. For example, CASGEVY™ is a CRISPR-Cas9
gene editing technique to disable an erythroid specific enhancer of BCL11A to reactivate fetal
hemoglobin gene expression and thus, HbF production. However, gene therapies carry significant
medical risks and costs in the millions per patient. Therefore, therapeutic development efforts to
discover new small molecule HbF inducers are still necessary. Here, based on a substantial
amount of preliminary data, we propose to develop orally bioavailable degraders of two fetal
hemoglobin gene repressors in order to elevate HbF levels and prevent erythroid sickling to treat
SCD. This proposal benefits from the strong complementary expertise and track record of the two
collaborating laboratories.

Public health relevance
Narrative Sickle Cell Disease (SCD) is terrible, debilitating disease that is a result of a mutation in a gene that encodes adult hemoglobin, the protein responsible for carrying oxygen in the blood. Before we are born, we use a different gene to make fetal hemoglobin, however this gene is switched off at birth. Here, we propose to develop a drug to treat SCD that would destroy this fetal hemoglobin off-switch, thus increasing the oxygen-carrying capacity by reestablishing fetal hemoglobin levels.